Development of a Full Qualification Package (FQP) for the PROMISnq Short Form v2.0 - Physical Function - Multiple Sclerosis 15a (DDT COA #000123)

ABSTRACT
Over 1 million people in the United States are living with multiple sclerosis (MS), a disease that
has significant impacts on physical functioning and, consequently, health-related quality of life.
However, a psychometrically sound, publicly available measure of physical function optimized for
persons with MS developed from the patient perspective has not been recognized by FDA as fit-
for-purpose for use in drug development. We propose the preparation and submission of a Full
Qualification Package (FQP) to support the qualification of the PROMIS / Quality of Life in
Neurological Disorders™ (Neuro-QoL™) Physical Function Measure for Multiple Sclerosis
(PROMISnq PFMS—15a) as a patient-reported outcome (PRO) measure of physical function in
people diagnosed with all forms of MS.
A measure of physical function was accepted into the Center for Drug Evaluation and Research’s
(CDER’s) Clinical Outcome Assessment (COA) Qualification Program under DDT #000123 on
June 21, 2017. The PRO Consortium’s MS Working Group selected the PROMISnq PFMS—15a
as the physical function measure for qualification as it has been optimized for use in persons with
MS and has qualitative evidence supporting its content validity. Next, a Qualification Plan (QP)
was submitted to FDA on November 29, 2021. The QP addressed the Working Group’s research
plan for obtaining quantitative evidence to support qualification of the measure. After FDA
acceptance of the QP, the next steps will be to analyze cross-sectional and longitudinal datasets
from the United Kingdom MS Register Study and the University of Washington MS Psychometric
Evaluation Study to generate quantitative evidence and to prepare and submit an FQP.
Our approach includes 3 aims. For Aim 1, we will analyze available cross-sectional and
longitudinal datasets that include the PROMISnq PFMS—15a in accordance with the accepted
QP and statistical analysis plan to document its validity, reliability, and responsiveness as an
outcome measure in people with all forms of MS. For Aim 2, we will prepare an FQP for the
PROMISnq PFMS—15a using the CDER COA FQP content outline and integrate all evidence
supporting the measure, including results of the completed qualitative and quantitative research.
Aim 3 will involve the submission of the FQP with all necessary appendices and attachments,
including a user manual and the associated analysis datasets and programming code. The goal
of this project will be a publicly available and accessible PRO measure for assessing physical
function in MS clinical trials for people with all forms of MS. As such, qualifying the PROMISnq
PFMS—15a will fill a critical gap in the measurement of physical function in MS treatment trials.

Public health relevance
NARRATIVE Although multiple sclerosis (MS) has a significant impact on physical functioning and is a major cause of non- traumatic disability in younger adults in the U.S., traditional endpoint measures in clinical trials focus on mobility and overlook impacts on upper extremity and other aspects of physical function that are important to people with MS; therefore, it is important that MS clinical trials measure the full range of physical function and the impact of new MS treatments on physical function. The overall objective of this project is to prepare and submit a Full Qualification Package to support the qualification of the PROMISnq Short Form v2.0 - Physical Function - Multiple Sclerosis 15a for use as a patient-reported measure of physical function among individuals diagnosed with all forms of MS. The impact of this work will be the advancement of a publicly available, psychometrically sound measure of physical function that can be used in MS treatment trials to better assess and understand the impact of new treatments on physical function in individuals with MS.